Excitability and Excitotoxicity in Type-I Cochlear Afferents: Synapse Structure and Function

Project Summary:
This project investigates the cochlear AMPA-type glutamate receptors (AMPARs) that are necessary for
hearing, overactivation of which leads to excitotoxic synapse loss and hearing disorders. Each cochlear
afferent synapse expresses many hundreds to a few thousand of these AMPARs, of both the Ca2+-permeable
subtype (CP-AMPARs, lacking subunit GluA2) and the Ca2+-impermeable subtype (CI-AMPARs, containing
subunit GluA2). The combination of pore-forming GluA subunits and auxiliary subunits of the AMPAR complex,
influenced by transsynaptic adhesion factors, determine its physiological properties and pharmacological
sensitivities. The cochlear AMPAR complex has properties that make it unique in the nervous system, for
example, the absence of GluA1. However, the precise complement of cochlear AMPAR subunits in not known.
This proposal uses mouse genetics, in vivo and ex vivo cochlear electrophysiology, proteomics, and
ultrastructural molecular anatomy to investigate the subunit composition, pharmacological sensitivity, and
functional significance of the cochlear AMPAR complex. We will determine the influence of auxiliary subunit
TARP-2 (Stargazin) on cochlear function, synaptic transmission, and GluA subunit expression. We will test
the hypothesis that synaptopathy in GluA3KO mice results from an increase in Ca2+-permeability of the AMPAR
complex. We will determine how Neuroligin1 and 3 affect AMPAR subunit expression and auditory nerve fiber
physiology. We will determine the influence of GluA3, TARP-2, Nlgn1, and Nlgn3 on the intrasynaptic
distribution of AMPAR subunits. With recombinant expression of different combinations of GluA pore-forming
and auxiliary subunits in HEK cells (with or without GluA3, with or without TARP-2), we will challenge our
understanding of the cochlear AMPAR complex by comparing changes in pharmacological sensitivity with
those changes observed for the native cochlear synapses (GluA3WT vs GluA3KO, TARP-2WT vs TARP-2KO).
The gain of this basic knowledge will inform design of small molecules to target cochlear AMPARs. With
chronic systemic administration of the tool compound (CP-AMPAR blocker IEM-1925), we will measure
synaptic adaptation and resistance to noise-induced synaptopathy. With acute systemic dosing, we will ask if
noise trauma can be prevented if IEM-1925 is given only during, not before, the noise exposure and if IEM-
1925 + antioxidant combination therapy can protect cochlear function from more intense noise exposures. The
long-term goal of this line of investigation is to develop systemic drugs to target CP-AMPARs of the inner ear
while allowing hearing function to be maintained through CI-AMPARs, and while avoiding unwanted CNS side
effects. The successful completion of this collaborative project will determine the precise subunit composition
of the cochlear AMPAR complex and its influence on pharmacological sensitivity.

Public health relevance
Project Narrative: Noise trauma is a leading cause of hearing disorders for which there are no cures, underscoring the need for prevention, but there are no FDA-approved pharmacological interventions to prevent hearing loss. We have shown that specific neurotransmitter receptors in the cochlea can be antagonized to prevent noise trauma while others remain active to mediate hearing, however, local delivery of drugs to a healthy cochlea is too invasive and systemic dosing is only tolerated if side effects can be avoided. This proposal investigates the precise molecular composition of AMPA-type glutamate receptor pore-forming and auxiliary subunits in the cochlea, so that they may be specifically targeted with systemic pharmacology.